Roles of body-wide injury responses in axolotl limb regeneration

ABSTRACT
Patients whose lives have been permanently altered by limb loss are currently left with prosthetic
options for restoration of function, but these are not perfect. Prostheses are limited in sensation, articulation,
and integration, among other concerns. Complete restoration of the lost limb via therapeutic intervention
remains a distant goal of regenerative medicine. This goal would be made significantly more tangible if a clear
roadmap for how complex tetrapod limbs can be regenerated was elucidated. Such a roadmap would detail
possible sources of progenitor cells and the cues that activate them to proliferate as well as instructions for
how these substrate cells undergo the changes necessary for them to be competent to build a new limb and to
do so with morphological precision. Since humans, mice, and other mammals do not naturally regenerate full
limbs, the roadmap is not likely to arise from mammalian studies alone. However, salamanders, such as
axolotls, are profoundly regenerative and can completely replace amputated limbs with precision throughout
life, and, with experimentation, they thus offer a chance to build this roadmap.
How processes that operate at the whole-body, systemic level to regulate progenitor cell activation and
blastema formation remain critical unsolved issues in the limb regeneration field. A blastema is the bud-like
structure that grows at the tip of the stump following amputation and contains the progenitor cells necessary to
build a new limb. The blastema is essential for regeneration, and, except for the distal-most dip of digits,
mammals do not form blastemas following limb amputation. Thus, understanding the controls, including the
system-wide responses and inputs, that govern progenitor cell activation and blastema formation in
salamanders is key to evaluating limitations observed in mammals. We hypothesize systemically-activated
cells promote local limb regeneration in axolotl salamanders. We further hypothesize that axolotls use the
hypothalamus-pituitary-adrenal (HPA) neuroendocrine system to stimulate systemic activation and that the
central nervous system coordinates injury responses to orchestrate limb regeneration. This project uses
modern tools, such as cell sorting and transplantation, paired scRNA-seq and ATAC-seq, and genome editing,
to understand the biology of systemically-activated cells. This project will also use implanted flexible-mesh
sensors and live neuronal activity recording for evaluating how the axolotl brain responds to limb amputation
and how its activity changes as limbs regenerate. This work will lay the basis for understanding how the CNS
may be required in the limb regeneration process. This project will provide important molecular and systems-
level insights into how a highly-regenerative tetrapod responds to amputation and, ultimately, grows a new
limb. It is therefore likely to have implications in regenerative medicine and evolutionary biology.

Public health relevance
NARRATIVE The large unmet need for more robust solutions to limb loss in human patients demands innovative solutions, and nature provides the ultimate inspiration in salamanders, which have limbs similar to human limbs but which completely regenerate following amputation. This project is aimed at understanding how axolotls, a kind of salamander, respond to amputation and create a blastema, a transient structure on the stump necessary for regeneration. We hypothesize axolotls coordinate the activity of tissue-resident progenitor cells, the neuroendrocrine system, and the central nervous system for the initiation of limb regeneration and blastema creation.